Scholars and Early-Stage Investigator Advancement Initiative (SEA)

Project Summary/Abstract
Not required for submission to Administrative Supplement to Cancer Center Support Grants (P30 CCSGs) to
Strengthen the Research, Training, and Outreach Capacity

Public health relevance
Project Narrative The Scholars and Early-Stage Investigator Advancement Initiative (SEA) is relevant to public health because it will develop a more diverse biomedical, cancer research and healthcare workforce to reduce cancer health disparities in New Jersey and nationally. This project at the Rutgers Cancer Institute of New Jersey will support and motivate scholars and Early-Stage Investigators from underrepresented groups to pursue careers in cancer and cancer health disparities.